Determining the role of the primate raphe-habenula circuit in multi-attribute decision-making

Value-based decision-making, driven by each individual’s own appraisal of available offers, is an indispensable
part of our lives and a key determinant of mental health. Internalizing disorders (e.g. depression, anxiety),
commonly feature maladaptive decision-making characterized by the assignment of erroneously low value to
rewarding activities and objects. Elucidating the neural basis of value-based decision-making is thus crucial for
understanding adaptive behavior and may provide translational insights. The lateral habenula (LHb) is thought
to act as the brain’s “bad news” center by broadcasting signals that decrease the value of rewards and is
implicated in depressive and anxiety-like behaviors. Moreover, LHb is known to receive strong inputs from the
raphe nuclei, the brain’s source of serotonin, a neuromodulator that is the target of most pharmaceuticals for
internalizing disorders and many other psychopathologies. The dorsal raphe (DR), the largest serotonergic
nucleus, is known to be involved in value-related processes, though the role of its inputs to LHb is unclear. In
particular, despite its potential importance, little is known about how the primate raphe-LHb circuit mediates the
complex strategies we use every day to choose activities and objects, a decision-making process which
requires integration across many reward attributes, such as amount, risk, and delay. We hypothesize that
LHb plays a central role in integrating attributes in order to compute the value of offers and guide
decisions online, using delay-related signals from DR to discount value. Aim 1 investigates the role of
LHb in multi-attribute decision-making. LHb signals are proposed to reflect preference integrated across the
many attributes that may define a reward and are ultimately broadcast to cortex and the basal ganglia, regions
with a prominent role in selecting actions. Preliminary data suggest that neurons in LHb integrate reward
attributes in a manner consistent with negative subjective value and that increasing LHb firing with weak
electrical stimulation during an offer’s presentation biases choice away from that offer in a manner consistent
with decreased offer value. Aim 2 investigates the role of DR multi-attribute decision-making. DR is proposed
to signal variables related to time delays until reward. If this is true in the context of decision-making, DR could
send delay and related attributes to LHb to guide decisions. Disruptions in this circuit could then interfere with
evaluation and choice of multi-attribute offers, and amelioration of such disruptions by antidepressants could
contribute to their therapeutic effects. Subsequent experiments will test the hypothesis that the sensitivity of
LHb and choice preference to reward delay is controlled by DR. These Aims will clarify the role of the primate
raphe-LHb circuit in multi-attribute decision-making, laying the groundwork for my future investigations of the
behavioral and neural systems that underlie internalizing and related disorders and undoubtedly opening the
door to new therapeutic avenues. Through these Aims, I will acquire the skills needed to successfully drive this
research as I develop into an independent psychiatrist-neuroscientist.

Public health relevance
Every day, humans and other animals make decisions based on our preferences. This project will investigate how the lateral habenula and dorsal raphe nucleus, both implicated in disorders such as depression and anxiety, are involved in these decisions, which are an indispensable part of our lives and a key determinant of mental health. Understanding the role of these structures in subjective decision-making will lay the groundwork for future investigations of the behavioral and neural systems that underlie depression, anxiety, and related disorders, and open the door to new therapeutic avenues.